RECIPROCAL FEEDBACK MECHANISMS OF GLIOBLASTOMA AND NEURONAL NETWORK HYPEREXCITABILITY

Glioblastoma (GBM) and tumor-related epilepsy (TRE) are intimately linked and devastating neurological
disorders lacking effective therapies despite decades of promising pre-clinical and clinical research. TRE is
reported in 40-60% of all GBM patients, often as the presenting symptom, and therefore new treatments would
be highly significant, not only for slowing tumor progression but also improving seizure-free quality of life. In
recent years, multiple lines of evidence have shown that malignant GBM cells can utilize numerous pathways
of interaction to drive peritumoral neural tissue into hyperactive states, thereby facilitating their own
proliferation and setting in motion a vicious feedback loop resulting in runaway disease progression in most
patients. Specifically, excess glutamate seems to be involved in many cellular neuron-glia interactions
including, increased synaptogenesis and hyperexcitability, and we now have evidence for specific genes
expressed in our genetic murine tumor model that drive malignant processes. However, we do not know how
these processes unfold over time in a native, immunocompetent mammalian tumor model, and how potential
therapeutic windows could be exploited to intervene and slow tumor growth. I propose to dissect the
mechanisms of tumor-induced glutamate dysregulation and, vice versa, tumor regulation by neural activity
using, for the first time, chronic in vivo cellular and macroscale imaging in a CRISPR/Cas9 genetic model of
GBM. We recently published the first widefield-calcium imaging study of this genetic GBM model and
characterized spatial and temporal profiles of seizures and spreading depolarization waves. We will use these
techniques, as well as cellular resolution 2-photon imaging, simultaneous EEG and behavioral monitoring to
address the following questions:1) How does GBM cause the degradation of glutamate homeostasis and
calcium activity over time? Using chronic widefield imaging of genetically expressed glutamate and calcium
activity indicators, we will follow neural activity and malignant glia invasion in vivo to determine spatial and
temporal dynamics of hyperexcitability and GBM growth. 2) How do these dysregulation dynamics change
when we perturb the genetic tumor driver composition? We will add genes encoding glypicans 3 and 6,
recently identified as synaptogenic proteins secreted by astrocytes, to our CRISPR/Cas9 construct. 3) How do
different methods of controlling neural hyperexcitability affect GBM growth? We will determine which targets
are more amenable to effective intervention than others by studying the effect of NMDA- and AMPA receptor
blockers over time in vivo. In addition, we will assess the contribution of non-synaptic glutamate release using
mice with a genetic deletion of the xCT cystine-glutamate astrocytic antiporter. Finally, we will directly silence
local peritumoral neurons using inhibitory DREADD constructs and measure subsequent GBM deceleration.

Public health relevance
Glioblastoma and tumor-related epilepsy are a pair of intimately connected neurological diseases with no curative or effective treatments available despite decades worth of preclinical and clinical research. Unlike previous studies that relied on tumor xenografts, we use a novel genetically induced, native mouse tumor model that recapitulates many hallmarks of the human disease progression, and that allows us to study the disease in vivo in an immunocompetent model organism. Here we propose to study the feedback loop of tumor invasion and neural hyperexcitability and explore potential interventions by mitigating the effects of excess glutamate or silencing focal groups of neurons to slow down tumor growth and reduce risk of epilepsy and other neurological comorbidities.